Linear diribonucleotides regulation of bacterial physiology and chronic biofilm infections

ABSTRACT
RNA degradation was thought to proceed through endonucleolytic fragmentation, followed by
exoribonuclease trimming which generate short RNA fragments that are turned over into mononucleotides
by oligoribonuclease (Orn). In the last funding period, we published data supporting that only specific
enzymes (Orn, NrnA, NrnB, and NrnC) are able to cleave diribonucleotides into monoribonucleotides, and
that prokaryotic organisms need to encode at least one diribonuclease to fulfill this specific function. These
results support a new perspective on RNA degradation in which the short oligoribonucleotides are processed
through a sequence of discrete steps involving distinct enzymes. In addition, linear diribonucleotides appear
to be biologically active molecules since we report that mutants lacking these enzymes accumulate
diribonucleotides and have altered cell growth, enhanced formation of biofilm, and sporulation defects. Here
we present additional preliminary data supporting diribonucleotides as active signaling molecules in the cell
including: 1. Specific enzymes generate diribonucleotides, 2. The only suppressor of Pseudomonas
aeruginosa ∆orn is a cryptic diribonuclease, 3. Two enzymes in central metabolism are diribonucleotide-
binding proteins, and 4. P. aeruginosa ∆orn has virulence defects in an animal model of catheter-associated
urinary tract infection. Our past publications and preliminary data provide the scientific premise for our
hypothesis that cells generate linear dinucleotides from RNA degradation and linearization of cyclic
dinucleotides, which can bind target proteins to alter cell physiology and pathogenesis. To test these aims,
we will perform the following specific aims: In Aim 1, we will characterize the generation and degradation of
diribonucleotides by determining the structure of diribonucleases and triribonucleases in complex with their
respective substrates and determine their biochemical functions. In Aim 2, we will identify effects of
dinucleotides on bacteria’s metabolism and physiology by characterizing the binding proteins that
specifically interact with linear diribonucleotides. Building on our success of identifying cellular
diribonucleotide receptors, we will screen for additional proteins from open reading libraries of Pseudomonas
aeruginosa and Bacillus antracis. We will exploit the strains available to us that lack all diguanylate cyclases
to reveal whether the effect of linear diribonucleotides is independent of c-di-GMP signaling. In Aim 3, we
will characterize the virulence defects of mutants lacking diribonucleases. We will employ existing mutants
lacking diribonucleases, including P. aeruginosa ∆orn and. Using P. aeruginosa ∆orn, we will study the
defects in chronic infection in a murine model of catheter-associated urinary tract infection. Results from
these studies will advance our understanding of RNA degradation and open a new area of signaling by
linear diribonucleotides with the potential to be applied to novel antibacterial strategies.

Public health relevance
NARRATIVE In our last funding period, we showed that specific enzymes have diribonuclease activity to cleave diribonucleotides to mononucleotides and that mutants lacking these enzymes have phenotypes involving growth and virulence. This proposal seeks to define how cells make and degrade diribonucleotides, how diribonucleotides bind proteins to alter their function, and diribonucleotides affects pathogenesis. Results from these studies will reveal how diribonucleotides act to regulate bacterial cell physiology and virulence.